Control of regulatory T cell fitness and function by heme synthesis

Project Summary/Abstract:
Despite advances in targeted immunotherapies, many treatments for autoimmune diseases remain ineffective
and can cause severe side effects, such as increased susceptibility to infections and cancer. Foxp3+ regulatory
T (Treg) cells play a critical role in preventing harmful immune responses, but their dysfunction can lead to
autoimmune diseases. The mechanisms behind Treg dysfunction are poorly understood, hindering the
development of effective Treg-based therapies. This proposal aims to investigate the novel role of heme
synthesis, identified through a CRISPR screen, in controlling Treg fitness and function. Preliminary data from
our lab show that Effector T cell Reprogrammed Tregs (ER-Tregs), which exhibit superior fitness and function
compared to naturally occurring Tregs (nTregs), are highly effective in ameliorating experimental autoimmune
encephalomyelitis (EAE), a model for multiple sclerosis. ER-Tregs maintain lineage stability, possess enhanced
suppressive function, and display a distinct gene expression profile, including the upregulation of Cpox, an
enzyme critical for heme biosynthesis. Cpox was identified as a key regulator of ER-Treg fitness, supporting their
proliferation, survival, and suppressive capacity. We hypothesize that Cpox promotes Treg expansion by
supporting mitochondrial oxidative phosphorylation (OXPHOS), sequesters labile iron to prevent ferroptosis, and
exports heme to enhance suppressive function. Our findings suggest that inadequate Cpox expression, due to
insufficient Foxp3 and tolerogenic signaling, contributes to Treg dysfunction in autoimmunity. Enhancing Cpox-
dependent heme synthesis may restore Treg function and alleviate autoimmune disease symptoms. The long-
term objective is to understand the role of Cpox and heme synthesis in Treg biology and identify potential
therapeutic strategies for rejuvenating Tregs in autoimmune diseases. To achieve this, we propose two specific
aims: Determine how Cpox promotes the fitness and suppressive function of ER-Tregs (Aim 1). We will examine
whether Cpox deficiency impairs Treg OXPHOS and causes ferroptosis, and whether the suppressive defects
in Cpox-deficient Tregs are related to their inability to export heme. These studies will use CRISPR-mediated
knockout and overexpression approaches. We will also investigate the regulation of Cpox expression and its role
in Treg dysfunction (Aim 2). We will map the regulatory pathways controlling Cpox expression using CRISPR-
based genetic and epigenetic tools and assess how Cpox impacts Treg homeostasis and function under steady-
state conditions and in EAE. We will also explore whether enhancing Cpox expression via epigenetic
reprogramming or overexpression can restore Treg function in EAE. These studies will provide crucial insights
into the role of heme biosynthesis in regulating Treg fitness and function, potentially leading to new therapies for
autoimmune diseases by restoring Treg function.

Public health relevance
Project Narrative: Autoimmune diseases often involve dysfunctional Foxp3+ regulatory T (Treg) cells, leading to harmful immune responses. This project explores the role of heme synthesis in regulating Treg fitness and function, with the goal of identifying new therapeutic strategies to restore Treg function in autoimmunity. By investigating how heme synthesis influences Treg stability and suppressive capabilities, and identifying regulatory mechanisms that control this pathway, the findings may offer novel approaches to improve Treg-based therapies for autoimmune diseases.